Genomic Competency Initiative

Project 1) Nursing Capacity in Pharmacogenomics: Findings from the Personalized Medicine Decision Making in a Virtual Clinical Environment study have been written into the primary paper. Qualitative data analysis was slowed due to COVID. All transcripts are complete and validation is ongoing. Once complete that data will be added to this paper which will then be submitted. The race IAT data has been transferred to NHGRI collaborators and analysis is ongoing. This and other studies indicate that advanced practice nurse curricular content in pharmacogenomics is inadequate. To address this deficit, working with colleagues in academics, we are planning to conduct a national assessment of pharmacogenomic curricular content and faculty capacity. In tandem, we will conduct a national survey of advanced practice nurses to assess their capacity. Both surveys has been developed and the project starting regulatory review at Indiana University. Instruments will be pilot tested in the fall at an academic nursing meeting and an advanced practice nurse meeting, refined, and then disseminated. Findings will inform development of a educational program for practitioners and faculty. Project 2) Omics Nursing Science and Education Network (ONSEN): The website is designed to facilitate achieving the Genomic Nursing Science Blueprint research priorities by facilitating collaborations, mentoring, and access to training opportunities to advance Omics nursing research and education. This project is funded by NINR. ONSEN has 3 sections: Education and Training provides information on mentoring, pre/postdoctoral opportunities, and a knowledge matrix to advance education and skills in genomic nursing science; Research Collaborations provides access to investigators conducting Omics nursing research who are interested in collaborations, sharing of samples and/or data; and Common Data Elements (CDE) provides information on the CDE benefits and links to resources. ONSEN content was developed by experts in genomics, Omics, education, practice, and nursing research. The publication describing the website development is published. An expanded ONSEN publicity campaign led by NINR was conducted since the last review. We will also conducted an ONSEN session at ISONG 11/2020 (virtually). Lastly, the advisory board recommended website enhancements which over the past year we worked with the vendor to create, test, and launch. NINR leadership however needed to address budget shortfalls and determined that website hosting by the vendor was too costly and decided not to extend the contract but to host directly on NINR. ONSEN came down on June 30th. NINR was provided with all the codes and content and indicate that they will be reopening the website on their site. Thus far this has not happened and there is no timeline for the website to re-open. 3) Global Genomics Nursing Alliance (G2NA): G2NA, established in 2017 led by the US, UK, and 23 global nursing leaders has grown to 118 nursing leaders. The G2NA website https://g2na.org/ has funding and support from the University of South Wales (USW); sustains quarterly education webinars; grown the countries represented; established a strategic plan; communicates through a listserv; completed or are conducting research projects described below; and secured funding from Wellcome in the UK, USW, and NCI for a global meeting on genomic implementation in nursing education and practice which postponed due the pandemic and held virtually 7/7-9/2021. There were more than 150 attendees, the final registrant numbers have not been provided by Wellcome, nor have the number of countries represented, or the evaluation data. The debriefing meeting with Wellcome is later in August where all this information will be provided. However, Wellcome indicated they found this meeting to be very successful for the first of its kind and feedback was positive and they are interested in supporting another meeting possibly in 2023 (every other year). The primary output from this meeting was to establish Communities of Practice that would address common global issues in genomic implementation, provide a platform for collaborative research, and address education issues. Three COPs were approved to move forward: Workforce Development; Clinical Practice; and Overcoming Barriers. The two primary research outputs from G2NA thus far, the Roadmap and the Maturity Matrix have both been adopted by England National Health Service and Health Education England in their country wide genomic implementation initiative which is inclusive of nursing. As this implementation moves ahead, large scale usability data on the Maturity Matrix instrument and the Roadmap will be conducted which will help refine both tools. Establish a Global Genomic Nursing Science Blueprint. This project starts with a systematic evidence review with a doctoral student from University of South Wales working with me. The first set of papers for review from the NIH librarian was delayed by months and did not arrive until 1/14/2021. There were 6388 papers for review all of which have been entered into Covidence. There are now 5 reviewers , 3217 papers have one vote, 1855 have been disqualified. We hope to have remaining papers reviewed and voted (2 votes/paper) by October 1. The doctoral student will coalesce the evidence at which time G2NA will convene a panel to review the evidence, identify gaps, and establish a Global Genomic Nursing Research Blueprint. The project to establish the Global Minimal Genomic Competencies for nurses and midwives was unable to move ahead in this reporting period due to COVID and that collaborators will all academic educators who had to transition to remote education. Methods have been established and the project now will launch in fall 2021. 4) The Genomic Nursing Competency Update: The Genetic/Genomic Nursing Competency Initiative developed and published The Essentials of Genetic and Genomic Nursing: Competencies in 2005. These competencies establish the minimum basis by which to prepare the nursing workforce to deliver competent genetic-and genomic-focused nursing care. A Second Edition in 2009 included Outcome Indicators consisting of competency specific knowledge and clinical performance indicators. Advances in genomic technology and evidence based clinical applications continue to impact nursing practice yet competency integration into practice and education remains uneven. Given expanding genomic applications, updated competencies are essential. An Advisory Board completed the update using a Delphi study. The American Nurses Association agreed to disseminate the competencies for public comment in March 2020 but this was postponed due to COVID. At the same time we submitted a proposal for a national nursing precision health and genomic competency initiative which was approved for assembly consideration cancelled ,due to COVID. In June 2021 we defended our proposal which was revised to include the public comment and updating the Graduate competencies followed by launching a national precision health and genomic implementation initiative. The proposal was approved by the assembly and with the Board of Directors for funding allocations. Lastly this project will conduct a hospital wide precision health and genomics nursing competency implementation study at the Cedars Sinai conglomerate using MINC study methods and the Roadmap and Maturity Matrix. This project will measure competency and implementation at baseline and at the conclusion of the study and compare usual hospital planned education/competency initiatives to intervention hospitals in the same healthcare hospital conglomerate. A post doc funded by NHGRI and ACMG will work with me on this study which in which I already have agreement from the hospitals.